Indiana Stimulating Access to Research in Residency (I-StARR)

SUMMARY
Housed at the Indiana University School of Medicine (IUSM), the country’s largest medical school, the Indiana
Stimulating Access to Research in Residency (I-StARR) program aims to train residents in research methods
focused on understanding and reducing health disparities in cardiovascular and pulmonary diseases. We focus
on primary care residency programs because their graduates enter clinical practice at the frontline of
prevention and treatment of highly prevalent cardiovascular, pulmonary, and related diseases. Despite the
availability of postdoctoral research training programs for clinician-investigators, programs tend to be linked to
subspecialty fellowships and do not engage trainees from primary care. Consequently, very few primary care
physicians purse research careers. I-StARR will recruit and train resident-physicians from residencies in Family
Medicine, general Internal Medicine, general Pediatrics, Medicine-Pediatrics, and general Obstetrics-
Gynecology. Over the five-year period of the award, I-StARR will train up to 12 resident-investigators, to be
recruited among the 446 residents of the five participating residencies. Our goal is to provide high quality
research skills training to place early-career clinicians on a structured pathway from resident-investigator to
clinician-investigator, equipping them with research skills and grant writing expertise along the way. We will
accomplish this by (1) enrolling residents in existing didactics in research methods, (2) providing career
development experiences, including a new grant writing curriculum for I-StARR residents, and (3) matching
resident-investigators with research preceptors for hands-on mentored research experiences for a minimum of
12 months at 80 percent effort. We designed I-StARR in three interdisciplinary tracks: clinical and translational
research, health services research, and community-engaged research. With a strategic focus on recruiting
residents with diverse backgrounds and experiences, we will train research preceptors in Culturally Aware
Mentoring. Grant-writing coaching and mentoring training will follow evidence-based best practices of the NIH-
funded National Research Mentoring Network. The evaluation arm of I-StARR will continuously monitor all
components and characteristics of the training program and incorporate feedback for quality improvement from
internal and external advisory boards. Applying a health disparities lens to the focus on cardiovascular and
pulmonary diseases, I-StARR will enable clinician-investigators to devise more effective intervention strategies
to improve population health especially for disadvantaged and marginalized populations.

Public health relevance
NARRATIVE The stated aim of the Indiana Stimulating Access to Research in Residency (I-StARR) program at Indiana University is to train up to 12 residents in five primary care residency programs to become clinician- investigators working to address cardiovascular and pulmonary diseases across an interdisciplinary spectrum of clinical and translational, health services, and community-engaged research. Applying a health disparities lens to the focus on cardiovascular and pulmonary diseases, I-StARR will enable clinician-investigators to devise more effective intervention strategies to improve population health especially for disadvantaged and marginalized populations.